Social Participation & psychological flexibility in chronic stroke survivors

Stroke survivors value return to social participation after rehabilitation. Social participation comprises
meaningful activities that involve interpersonal interactions with family, friends, peers, and community
members. Restrictions in social participation begin when stroke survivors re-enter the community after hospital
discharge and persist for several years. Failure to return to social participation has significant long-term health
consequences including social isolation, depression, sedentary behavior, and subsequent chronic illness.
Strategy training (ST) uses iterative practice of meaningful activities with structured instruction and feedback.
While strategy training shows promise for optimizing social participation outcomes in stroke survivors, there is
a need to further examine whether strategy training addresses psychological processes that impact social
participation, such as fear of embarrassment. Acceptance and Commitment Therapy (ACT) provides additional
tools to address these psychological processes and improves psychological flexibility (acceptance, reduced
avoidance) and shows promise for improving social participation among stroke survivors. By combining ACT
with structured practice, as is possible when combining ACT with ST, rehabilitation providers may help stroke
survivors resume social participation. We will examine the feasibility of a randomized controlled trial that
compares the synergistic effects of ST+ACT to ST alone for social participation, psychological
flexibility, and well-being outcomes for community-dwelling chronic stroke survivors. Participants will be
randomized to receive either 10 sessions (2 times per week for 5 weeks) of a manualized ST+ACT or a
manualized ST intervention. We will compare participant retention (percent who complete all procedures) and
engagement (mean Pittsburgh Rehabilitation Participation Score), as well as intervention dose (total
intervention minutes), fidelity (percent of sessions with fidelity ≥80%) and satisfaction (mean Client Satisfaction
Questionnaire score) between groups. We also hypothesize that ST+ACT will be associated with significantly
greater improvements in social participation (primary outcomes: PROMIS Ability to Participate in Social Roles
and Activities and PROMIS Satisfaction with Participation in Social Roles), psychological flexibility (secondary
outcome: Multidimensional Psychological Flexibility Inventory), and wellbeing (secondary outcome: RAND 12-
item Health Survey), compared to ST alone, after intervention and 1 month later. Our study directly addresses
priorities specified within the NIH Research Plan on Rehabilitation focused on optimizing rehabilitation to
promote social participation and wellbeing for people with disabilities. Furthermore, our study provides critical
pilot data to inform future large scale clinical studies seeking to optimize social participation, wellbeing, and
health after stroke.

Public health relevance
Low social participation is associated with social isolation, sedentary behavior, depression, anxiety, and chronic illness. Return to social participation is a top priority stroke survivors but is currently neglected in stroke rehabilitation. However, psychological fears can impede social participation after stroke. We will examine the feasibility of a randomized controlled trial that compares the effects of a synergistic new intervention, combining acceptance and commitment therapy with strategy training (ST+ACT), versus strategy training (ST) alone for community-dwelling stroke survivors. We will also compare the changes in social participation, psychological flexibility, and wellbeing over time in participants who receive either ST+ACT or ST alone.